COUPLED ACOUSTICAL WAVE MICROPILLAR DETECTION OF DRUGS IN BLOOD POSTMORTEM

Drug Diagnostics Including Fentanyl Strips/CODE (Cause of Death Elucidated) in Drug Overdose: Rapid and portable cause of death detection technologies to improve drug overdose-related mortality counts